Administrative Core

2. PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core will be responsible for the overall administration of Consortium operations. Oregon
Health & Science University will house the coordinating center for the consortium. The Administrative Core will
oversee the finances of the consortium, establish all policies and procedures of the consortium, maintain
communication between the clinical research sites in the consortium and our advocacy group partner the
NPKUA, and maintain communication with the Rare Disease Clinical Research Network (RDCRN) and the
Office of Rare Diseases Research (ORDR) at the National Institute of Child Health and Human Development
(NICHD). The Administrative Core will be responsible for the management of data between the consortium
sites to the Data Management Coordinating Center (DMCC) and will also be responsible for the study design
and biostatistical analysis of the data. Core personnel will be responsible for regulatory compliance across the
consortium including preparation and submission of IRB protocols and development of Data Safety Monitoring
Plans.